Notch regulation of airway epithelial-immune cell cross-talk in SARS-CoV-2 infection

Abstract
Severe Acute Respiratory Syndrome Coronavirus 2 (SARS-CoV-2) is the causative agent of COVID-19. Infection
with SARS-CoV-2 begins in epithelial cells of the upper airways, which triggers multiple antiviral responses that
activate myeloid immune cells, coordinate the early innate immune response, and limit viral spread. Notably, our
understanding of the cell signaling mechanisms that regulate early epithelial-immune cell interactions and
induction of tissue pathology during SARS-CoV-2 infection of the human airway remains limited. To investigate
these processes, we have developed a novel in vitro all human 3D model of the upper airways (HUA) composed
of layers of primary differentiated airway epithelial cells expressing ACE2, lung fibroblasts in a collagen matrix,
and pulmonary endothelial cells, with myeloid cells present in each layer. SARS-CoV-2 infection of the HUA
model results in virus replication and induction of an immune response reminiscent of in vivo infection, and the
presence of myeloid cells limits viral replication. Therefore, we will use the HUA model to perform kinetic studies
of the mechanisms by which human airway cells interact to regulate virus-host interactions, inflammation, and
tissue pathology associated with SARS-CoV-2. We will focus on the Notch pathway, which acts via direct cell-
to-cell signaling to regulate airway epithelial cell fate decisions as well as myeloid cell maintenance, Toll-like
receptor signaling, pro-inflammatory polarization, and antiviral functions. However, the mechanisms by which
Notch signaling regulates airway epithelial-myeloid cell interactions during SARS-CoV-2 infection remain
unknown. Our preliminary analyses showed that airway epithelial cells and myeloid cells express multiple Notch
ligands and receptors in uninfected HUA models, suggesting that the Notch pathway will mediate bidirectional
crosstalk during the airway response to infection. We will test the central hypothesis that Notch receptor signaling
in myeloid cells regulates their pro-inflammatory phenotype, thereby promoting the host innate antiviral immune
response and contributing to airway epithelial cell damage and remodeling during SARS-CoV-2 infection. Using
lentivirus vectors and inducible expression systems, we will attenuate expression of individual Notch ligands and
receptors in a cell-type specific and temporal manner. Following SARS-CoV-2 infection, we will quantify the
impact of reducing Notch signaling activity on virus replication, myeloid cell phenotypes, the host immune
response, and airway epithelial remodeling. The data collected in this study will advance our understanding of
the mechanisms that regulate airway epithelial-immune cell interactions during SARS-CoV-2 infection and may
identify candidate therapeutic targets in the Notch pathway to enhance antiviral immunity and reduce epithelial
injury and remodeling in the upper airway.

Public health relevance
Narrative We do not fully understand how immune cells interact with lung structural cells to mediate balanced responses to respiratory viruses. To address crosstalk between cell types, we will build unique in vitro tissue models that mimic the environment of a normal human lung by containing lung structural cells and immune cells isolated from healthy individuals. We will infect this lung tissue model with the Omicron strain of SARS-CoV-2 and determine how different types of cells interact to produce antiviral responses and enact lung damage and repair.